Cardiac microlesion formation during invasive pneumococcal disease

One-in-five adults hospitalized for Streptococcus pneumoniae (Spn, the pneumococcus) pneumonia
experience a major adverse cardiac event (MACE) with affected individuals four times more likely to die than
those with pneumonia alone. Spn-associated MACE is the result of the physiological stress imposed on the
heart as well as direct cardiac damage caused by harmful bacterial products. This competitive Multi-PI R01
renewal is focused on identifying the molecular mechanisms underlying the hyper-virulence of Global
Pneumococcal Sequence Cluster 10 (GPSC10). GPSC10 is a globally distributed and expanding genetic
lineage of Spn which causes MACE at 2.5-fold the rate of all other GPSC. Moreover, GPSC10 is multi-drug
resistant and has member isolates carrying serotypes not covered by the newest 20-valent conjugate vaccine.
Thus, current prophylactic and therapeutic approaches against GPSC10 are inadequate. Our goal is to
identify the genetic determinants responsible for GPSC10 hyper-virulence and determine if the encoded
proteins are viable targets for intervention. Our hypotheses are: 1) genes present in GPSC10 and absent in
non-invasive / non-cardiotropic GPSC are responsible for its enhanced virulence, and 2) virulence
determinants encoded by these genes can be blocked for protection against severe disease, cardiac
damage, and MACE. Note, that in pilot studies we have already determined that a particular allele of zmpB, a
gene encoding a zinc metalloprotease (Zmp), is disproportionately present among GPSC10 isolates; that an
isogenic zmpB deficient mutant, i.e., ∆zmpB, had substantially reduced capacity to cause cardiac damage in
mice versus wildtype Spn; and collected data that suggests immunization with recombinant (r)ZmpB is
protective against cardiac damage following invasive disease. Thus, our chosen approach is strong.
AIM 1: Identify the genetic determinants responsible for GPSC10 hyper-virulence and cardiac tropism.
Using Spn whole genome sequences, deidentified metadata corresponding to in-house clinical isolates, and
results obtained from mice experimentally challenged with clinical isolates, we will perform multiple bacterial
genome wide association studies (bGWAS) to identify the genetic elements whose presence correlate with
GPSC10 hyper-virulence. Genes identified as associated with cardiac damage will be deleted in diverse Spn,
including GPSC10, and their contribution to disease verified in vivo.
AIM 2: Determine how ZmpB contributes to cardiac damage and assess the protective efficacy of
antibody. We will confirm the role of ZmpB not only in acute cardiac injury, but also with regard to the adverse
cardiac remodeling and dysfunction that takes place post-infection. We will determine the molecular basis for
its secretion, a novel feature of ZmpB versus other zinc metalloproteases found in Spn and determine the
impact of blocking this process on virulence and disease. We will test if immunization with ZmpB confers
cardiac protection and whether passive administration of antibody has therapeutic efficacy.

Public health relevance
PROJECT NARRATIVE One-in-five adults hospitalized for Streptococcus pneumoniae (Spn) infection experience a major adverse cardiac event (MACE). GPSC10 is a globally distributed and expanding genetic lineage of Spn which causes MACE at 2.5-fold the rate of all other Spn. We will perform bacterial GWAS to identify the genes associated with GPSC10 hyper-virulence, validate their importance using isogenic mutants, and determine if blocking their activity, with pharmacological agents or antibody, confers protection against cardiac damage.